Fluorescence image guided surgery, adjuvant PDT, and the immune response

Abstract. Prostate cancer (PCa) is the most prevalent cancer among men in the United States and radical
prostatectomy remains one of the three treatment options for these patients. Screening with serum prostate specific antigen
(PSA) allows for 78% of prostate cancers to be diagnosed at the early localized stage, facilitating therapy with radical
prostatectomy (RP) or radiation therapy. However, ∼ 20% patients present with high-risk PCa, i.e., positive surgical margins
(PSM) discovered after surgery during pathology of resected tissues. These patients with high-grade tumors also have a
high risk of biochemical recurrence (>60%) and will ultimately develop lethal metastatic disease. Surgical approaches to
prostate cancer are also associated with significant morbidity, e.g. incontinence (3-74%) and impotence (30-90%) due to the
close proximity of the prostate gland to critical nerves and muscles. Therefore, there remains an unmet clinical need to
improve surgical techniques for identifying and removing all cancerous tissue without damaging surrounding tissues during
prostatectomy and to prevent relapse.
The goal of this study is to provide a means to address both unmet needs, i.e., to more completely remove cancers
and at the same time generate an immune response to help prevent local recurrence and metastatic disease. In the proposed
study we will develop a precisely targeted theranostic agent, PSMA-1-Pc413, for both fluorescence guided surgery and
photodynamic therapy (PDT) to effectively treat prostate cancer. The overall approach is to use the highly expressed and
tumor selective prostate specific membrane antigen (PSMA) biomarker to target a highly fluorescent and potent
photosensitizer, Pc4, to prostate cancer tumors. Following IV injection and recognition of the PSMA receptor on prostate
cancer cells, PSMA-1-Pc413 will be used for fluorescence image guided surgery to remove the PCa from the flank of mice.
Following excision, the surgical field will be irradiated with light to stimulate PDT to remove any non-visible or non-
resectable cancerous cells. Furthermore, PDT may stimulate a local and even systemic immune response limiting local
recurrence and metastatic disease. We will first test our hypothesis in immune competent syngeneic mouse prostate cancer
models. Since efficacy trials in mice are not always predictive of human results, we will also test the approach in an
orthotopic canine prostate cancer model; dog pathology and physiology of prostate cancer is very similar to humans and
dogs are often used in drug development trials. After probe injection, PDT will be performed and the canine prostate gland
and any extra-glandular cancer tissues will be resected. Correlation of the probe to cancerous tissues and the impact of PDT
on cancer and surrounding normal tissues will be assessed using histopathology. Targeting and PDT studies in dogs will
substantially encourage the potential to use this agent in dogs with spontaneous forming prostate cancers (beyond the scope
of these studies) and clinical translation of the developed agent. Our innovative, combined theranostic approach, if
successful, will significantly alter the way prostatectomies are performed in the future by: 1)increasing surgical efficacy;
2) prolonging progression-free survival; and 3) decreasing morbidity. No such approach has been reported for PCa.

Public health relevance
Narrative This research projects intends to fully develop the theranostic capabilities of a targeted fluorescence imaging probe, PSMA- 1-Pc413, that has been used for image guided surgery and photodynamic therapy. This will be accomplished using a syngeneic mouse model of prostate cancer to perform image guided surgery and PDT measuring its stimulation of the immune system. A canine model will be utilized to perform imaged guided surgery followed by PDT and measure collateral damage to surrounding tissues.